HIV latency driven microgliosis

Highly active antiretroviral therapy effectively targets viral replication but fails to eliminate proviruses in
long-lived cell populations. Our knowledge of HIV persistence in the human brain remains limited. Microglia are
the resident innate immune cells of the central nervous system. Our preliminary data indicate that HIV infection
of primary human microglia cells results in proliferation (termed microgliosis). Our reporter HIV vector
toolkit termed pMorpheus allows examination of latency establishment at the single cell level using
microscopy and flow cytometry approaches. We hypothesize that HIV infection induces microgliosis by
clonal expansion of latently infected microglia cells. This proposal leverages our pMorpheus based primary
human microglia model system to experimentally test this hypothesis. We propose to investigate productive
and latent HIV infections in depth in human primary microglia cells isolated from post-mortem brain
tissues (Aim 1) and to identify biomarkers and cellular rewiring characteristic of HIV associated
microgliosis (Aim 2). The experiments outlined in this high risk/high reward R21 application will not
only fill critical knowledge gaps in our understanding of HIV latency establishment in primary human
microglia cells but also inform on biomarkers of microgliosis and neuro-degeneration.

Public health relevance
Our understanding of HIV latency establishment and maintenance in long-lived immune cells of the brain is currently very limited. Our proposed studies will fill these knowledge gaps in order to develop therapeutic strategies that will limit HIV persistence in specific anatomical compartments like the brain.